Functional Organization of Posterior Parietal Cortex

DESCRIPTION (provided by applicant): Short-term maintenance of information is a fundamental aspect of human cognition that is compromised by a wide variety of mental health disorders including: Schizophrenia, ADHD, substance abuse disorders, Alzheimer's disease, Parkinson's disease, and AIDS related dementia. A deeper understanding of the basic neural mechanisms underlying short-term maintenance will lead to improved diagnostic, prognostic, and therapeutic procedures for these disorders. The proposed research will focus on three types of short-term maintenance: sensory attention, motor intention, and working memory. It is widely believed that sustained neural activity during a delay interval is the mechanism by which the brain performs these three cognitive processes. Posterior parietal cortex (PPC) has emerged as a particular focus for research on sustained delay-period activity related to attention, intention, and working memory. The proposed experiments will use fMRI to measure cortical activity in human subjects while they perform three closely related but complementary tasks that differ in their dependence on sensory attention, motor intention, and working memory. In the first task, subjects will perform an eye movement to a remembered location. In the second task, subjects will detect a luminance decrement at a cued location. In the third task, subjects will detect a small shift in the remembered location of a target. These three tasks place differential demands on intention, attention, and working memory. The first task emphasizes motor intention;in this task subjects will make eye movements to remembered locations whereas in the other two tasks they will have to accurately hold fixation. The second task emphasizes sensory attention;in this task subjects will attend to targets that are constantly illuminated whereas in the other two tasks they will remember the locations of targets that are no longer visible. The third task emphasizes spatial working memory;in this task subjects will remember the location of a target for later comparison whereas no spatial comparison is involved in the other two tasks. These three tasks will be used to achieve two central aims concerning the homology between human and monkey PPC and the functional role of human PPC in sensory attention, motor intention, and working memory. The first aim is to define each of several cortical areas, using experimental protocols that measure topographic representations of attention, intention, and working memory. The second aim is to test the hypothesis that these now pre-defined human cortical areas are functionally homologous to cortical areas in monkey PPC (particularly monkey area LIP), and to test the hypothesis that behavioral performance of each of the three tasks depends on the level of delay-period activity in these human cortical areas.